The Impact of Disrupting Sensory Innervation on Tibial Bone Mass

PROJECT SUMMARY
Tibia and fibula fractures account for 10% of annual osteoporotic fractures leading to significant morbidity with
a 10% mortality rate within 12 months of fracture. Low bone mineral density can dramatically increase fracture
risk resulting from a decrease in bone formation by the osteoblast, an increase in bone resorption by the
osteoclast, or both. A greater understanding of factors regulating tibial bone mineral density will help prevent
tibial fracture through identification of at-risk individuals and treatment of low tibial bone mineral density.
Sensory nerves signal to and from bone. Both signaling directions are critical aspects of bone homeostasis and
bone health. Sensory nerve communication with bone has been linked to an increase in bone mineral density
through direct and indirect communication between sensory nerves and both osteoblast and osteoclasts while
denervation is linked to reduced bone mass. However, it is unclear what impact long-term disruption of these
signaling pathways has on bone health. The saphenous nerve is primarily a sensory nerve with no known
motor function. Injury to the saphenous nerve results in pain, numbness, and denervation of the nerve itself.
Preliminary studies have demonstrated that the saphenous nerve innervates the tibia in mice. Preliminary data
has shown that transection of the saphenous nerve reduces tibial nerve fiber density by 45-60% in the
proximal, lateral-most periosteum of the tibia. However, the impact of saphenous nerve injury on tibial bone
mineral density is unknown. We hypothesize that saphenous nerve denervation will alter bone remodeling
within the tibia resulting in reduced bone mass. In order to test this hypothesis, Aim 1 will characterize the
impact of saphenous nerve transection on tibial bone mass and innervation. These data will determine whether
denervation of the tibia will result in a decreased bone mineral density, microarchitecture, cell number, and
turnover. It will also further identify regions of innervation loss within the tibia following saphenous nerve injury.
In an effort to delineate the mechanism of sensory regulation of bone, Aim 2 will assess the relative
contribution of sensory nerve fiber subtypes on tibial bone mass through chemical ablation of peptidergic and
non-peptidergic sensory neurons using resiniferatoxin and IB4-Saporin, respectively. As CGRP has been
demonstrated to promote bone anabolism, we hypothesize that selective ablation of peptidergic sensory fibers
will result in bone loss whereas selective ablation of non-peptidergic sensory fibers will not alter bone
remodeling or bone mass. These data will reveal the sensory nerve fiber subtype necessary for maintaining
bone mineral density. The proposed studies will define the saphenous nerve as an important regulator of bone
homeostasis in the tibia. A greater understanding of the impact of nerve injury on bone mass will aid in
elucidating new risk factors predisposing individuals to tibial fracture.

Public health relevance
PROJECT NARRATIVE Fracture of the tibia and other osteoporotic fractures have a heavy societal burden with devastating consequences including morbidity and death. This project explores the role of saphenous nerve injury in controlling tibial bone mineral density through sensory nerves. A greater understanding of the impact of nerve injury on bone mass will aid in elucidating new risk factors predisposing individuals to tibial fracture.